Role of circulating Osteopontin and of Innate Immune Cell CD44 in Tissue Injury-induced Remote Lung Inflammation

PROJECT SUMMARY ABSTRACT
The overall goal of our research is to develop novel strategies to prevent or treat secondary organ complications
in multiorgan failure. Acute kidney injury frequently negatively impacts oxygenation in multiorgan failure, causing
very high mortality due to a lack of therapies. Molecular mechanisms and mediators of this detrimental kidney-
lung crosstalk are incompletely understood. We recently identified circulating osteopontin (OPN, Spp1) released
by the injured kidney after acute kidney injury as a novel key mediator of remote lung inflammation with
respiratory failure. Consistent with this, elevated OPN serum levels correlate with increased mortality and need
for ventilation in multiorgan failure patients. OPN can interact with integrins and CD44 receptors and possibly
through its two thrombin cleavage fragments. It is unknown which OPN receptor interactions are required for
remote lung inflammation, which cells OPN targets, and which signals downstream of OPN attract neutrophils to
lung capillaries. Our central hypotheses is that OPN or its thrombin-cleaved fragments bind to its receptor(s)
integrin and/or CD44 on innate lung immune cells that in turn produce signals that attract neutrophils to lung
capillaries. Our preliminary work provides evidence for a role of OPN in CD44+ innate lung immune cells in
remote lung inflammation and for signals they produce that attract neutrophils. The rationale for this project is
that completion will for the first time (1) identify lung target cells and receptors of remote lung inflammation, (2)
define OPN domains involved in remote lung inflammation, and (3) directly visualize initiation of remote lung
inflammation and the effect of blockade of predicted innate immune cell-derived neutrophil chemoattractant
signals in vivo. We plan to test our central hypotheses with three specific aims: Aim 1: Determine which OPN
domains are required to induce remote lung inflammation and whether OPN thrombin cleavage is required. We
will test (1) whether OPN or OPN mutants reverse protection of AKI-injured OPN-KO mice when injected or (2)
induce signaling and production of cytokines in monocyte or macrophage cell lines. We will also test knock-in
mice with a mutation that renders OPN uncleavable by thrombin. Aim 2: Determine whether CD44 in lung innate
immune cells is required for remote lung inflammation. We will (1) test cell-type specific knockout of CD44 in
innate immune cells or transplantation approaches in remote lung inflammation and (2) test for OPN:CD44
interaction and CD44’s requirement for OPN action in remote lung inflammation. Aim 3: Test innate immune cell-
derived signals predicted to recruit neutrophils in remote lung inflammation. Using intravital two-photon imaging,
we will directly visualize initiating steps of remote lung inflammation after AKI and test the effect of blocking
predicted neutrophil attractant signals. This contribution is significant because it is expected to have translational
impact in the development of treatments for detrimental kidney-lung crosstalk in multiorgan failure, complications
with high mortality. Our research is innovative, in our opinion, because it would identify critical mediators, target
cells types, and mechanisms in remote lung inflammation, and provide guidance for translation into patients.

Public health relevance
PROJECT NARRATIVE Sterile tissue injury e.g. by ischemia or trauma can induce a systemic inflammatory syndrome with remote organ inflammation and dysfunction. Sterile ischemic acute kidney injury (AKI)-associated worsening of respiratory failure in multiorgan failure patients is common but not well understood mechanistically, causing high mortality due to lack of therapeutics. The proposed research is relevant to the mission of the NHLBI, NIGMS, or NIDDK, as it may lead to the development of novel therapeutic options in multiorgan failure and could significantly impact suffering and health care expenditure.